DP21-001 Hawaii Pregnancy Risk Assessment Monitoring System (PRAMS)

2021-2026 PRAMS Application Identifier: 801548
Hawaii (July 2020)
Hawaii PRAMS Project Summary
The Hawaii Pregnancy Risk Assessment Monitoring System (PRAMS) Program
is a population-based surveillance system designed to identify and monitor maternal
experiences, attitudes, and behaviors from preconception, through pregnancy and into
the interconception period. Hawaii PRAMS provides ongoing monitoring of maternal
behaviors to determine how to reduce infant deaths, decrease low birth weights and
improve the overall health of the population in Hawaii.
The overall goal of Hawaii PRAMS is to reduce infant morbidity and mortality by
impacting maternal and child health programs, policies and maternal behaviors during
pregnancy and early infancy. There are four PRAMS objectives: 1) Collect high quality
population-based data on maternal behaviors before and during pregnancy and during
the early life of the infant; 2) Conduct epidemiologic analysis and study of maternal
behaviors and experiences during pregnancy and early infancy and the relationship to
health outcomes; 3) Translate data analyses into useable information for program
planning, monitoring and evaluation; and 4) Increase public awareness of healthy
pregnancy behaviors to improve maternal health across the life span.
A PRAMS questionnaire is mailed to approximately 200 new mothers per month
on all major islands of Hawai‘i. The new mothers are identified by the Office of Health
Status and Monitoring (OHSM), Hawai‘i Department of Health, from the birth certificates
of recently born infants. The Hawaii questionnaire includes questions that are asked by
PRAMS programs in all states as well as standard questions selected for inclusion by
the Hawaii PRAMS Program, in partnership with the Hawaii PRAMS Steering
Committee, other Department of Health program staff, and local healthcare providers.
The questionnaire addresses priority maternal and child health issues such as
unintended pregnancies, smoking and alcohol use during pregnancy, insurance at time
of pregnancy, contraception, post-partum depression and domestic violence. Hawai‘i
PRAMS standard questions address topics such as breastfeeding, dental care, drug
use, general health, HIV, and maternal health conditions.

Public health relevance
2021-2026 PRAMS Application Identifier: 801548 Hawaii (July 2020) Hawaii PRAMS Project Narrative The mission of the Hawaii State Department of Health is to protect and improve the health and environment for all people in Hawaii .The Hawaii Pregnancy Risk Assessment Monitoring System (PRAMS) Program fulfills this mission through collecting and analyzing both quantitative and qualitative data on maternal behaviors before, during, and immediately after pregnancy. The information from Hawaii PRAMS is invaluable to providers, policy makers, and program managers who use it to design prevention, treatment, and education programs and policies to increase the health of women and infants in Hawaii.